Training Program in Psychiatric Genetics and Translational Research

7. Abstract
This competitive renewal application is for continuation of the Training Program in Psychiatric
Genetics and Translational Research, offered by the Departments of Epidemiology,
Biostatistics, and Social & Behavioral Sciences at the Harvard T.H. Chan School of Public
Health. The principal objectives of the training grant are to educate promising pre- and
postdoctoral trainees as quantitative scientists in psychiatric research, with two focus areas:
psychiatric genetics and analytical methods for translational research. This renewal expands the
training program to include the Department of Social & Behavioral Sciences in order to
strengthen the program’s focus on translational research, particularly with reference to social
epidemiology, diverse populations, and understanding social disparities. We aim to train
psychiatrists and other mental health researchers in methods relevant to these fields, and to
train methodologists working in these areas with genuine engagement in psychiatric research
and an understanding of psychiatric diagnosis, assessment, and outcomes. The Departments of
Epidemiology, Biostatistics and Social & Behavioral Sciences have an accomplished faculty
who have worked collaboratively in genetics and translational research for many years. We also
draw on the expertise of Harvard faculty from other world-renown institutions, including Harvard
Medical School, Massachusetts General Hospital, Brigham & Women’s Hospital, and McLean
Hospital. These collaborations offer a rich source of ongoing projects for student and
postdoctoral training. We are requesting a total of seven trainees across the three departments,
three predoctoral and four postdoctoral (typically two clinical scientists [psychiatrist or clinical
psychologist] seeking a masters or doctoral degree and two traditional postdoctoral fellows).
Training will be a combination of coursework, seminars, practica, and independent and
collaborative research in mental health. High-level training in the core disciplines of
epidemiology, biostatistics, and social and behavioral research, properly accounting for diversity
and health disparities is critical to leadership of mental health research in the coming decades.

Public health relevance
8. Narrative Scientific advances in genetics require complex and novel methods and their application in the complex setting of psychiatric disorders. To reduce the suffering and disability related to mental illness in society, clinical research needs to translate findings from genetics and ongoing developments in the neurosciences into better treatment, prevention, and healthcare strategies. Both psychiatric genetics and translational research need to address underrepresented populations and the impact of health disparities in order to improve population mental health.